Biostatistics

Core A is organized to meet demonstrated statistical needs of participating scientists in the areas of biostatistical design and analysis, and data management. Please see the Appendix for additional descriptions of biostatistical methodology. The objectives of Core A are as follows: 1. To assist in the biostatistical design of clinical and laboratory studies in this Program Project Grant (PPG). 2. To assist in the analysis of research data. In this role, the core provides assistance to multiple investigators in implementing study protocol design, data entry, data monitoring and analysis and manuscript w r i t i n g . 3. To provide experienced staff to carry out analyses. 4. To assist investigators in all aspects of data management including the organization of their data flow and in the choice and setup of data base management systems. 5. To develop biostatistical methodology for statistical problems arising in this PPG. 6: To provide scientific input more generally as a member of the Executive Committee.

Public health relevance
Core A will support all three projects and work closely with other Cores, especially with respect to analyzing data from the trial in combination with the archival patient material. To develop further support for Projects I, II and III we have been pursuing various statistical methodologies for the handling of incomplete data.